An Investigation of Omics for Bronchopulmonary Dypslasia

PROJECT SUMMARY
Bronchopulmonary dysplasia (BPD) is the most common and serious complication of prematurity. Disruptions
in lipid metabolism may be associated with respiratory complications in preterm infants but remain incompletely
characterized. The lack of reproducible biochemical markers for BPD has limited the translational application of
established and novel therapies. To address this gap, Aim 1 will identify distinct lipid and metabolomic profiles
associated with the respiratory severity score at birth. Aim 2 will conduct longitudinal metabolomic profiling in
preterms as part of the prospective Longitudinal Omics in Neonates (LION) study. Here we will identify
metabolic trajectories over time in association with BPD cases and controls. Aim 3 will examine a subset of
LION study patients at risk for severe BPD and receiving mechanical ventilation. Longitudinal tracheal aspirate
samples obtained from this subcohort will be interrogated in multi-omic fashion for single-cell RNA sequencing
and targeted lipidomics. Correlation and multi-omic analyses will link cellular programming events with
lipidomic profiles. All aims rely on targeted and agnostic machine learning-based approaches while leveraging
known biochemical mechanisms. Dr. Reiss is supported by a world-class mentoring and scientific advisory
committee including experts in omics for maternal-child health (David K. Stevenson, Michael P. Snyder, Karl G.
Sylvester), epidemiology (Gary M. Shaw), machine learning (Nima Aghaeepour), lipid biochemistry (Jonathan
Z. Long, Camilia Martin), and developmental pulmonary biology and immunology (Lawrence S. Prince). The
career development plan will complement the proposed scientific investigations by examining 1) Epidemiologic
Methods & Analytic Approaches for Omics; 2) Lipid Metabolism and Biochemistry for Newborn Lung Health
and Disease and 3) Single-cell RNA sequencing (scRNA-seq) in BPD. This award will leverage Dr. Reiss’s
expertise in clinical metabolomics and machine learning for neonatal disease and build towards his long-term
goal of becoming an independent physician-scientist using omic approaches to identify novel biomarkers and
pathways for translational discovery in BPD.

Public health relevance
PROJECT NARRATIVE Bronchopulmonary dysplasia (BPD) may be driven by bioactive lipid and metabolomic intermediaries that have been incompletely characterized. This proposal will identify biochemical perturbations associated with BPD using complementary lipidomic, metabolomic and transcriptomic approaches. The findings have the potential to identify putative biochemical markers and novel molecular patterns associated with BPD.